Genetic architecture of the human brain and neuropsychiatric disorders

Project Summary
Our goal is to determine gene-brain-behavior relationships, including those that underlie neuropsychiatric
disorders. These disorders are common and increasing in incidence worldwide. However, there are significant
clinical gaps in current treatment and objective diagnosis. Drug development trial failure rates are
disproportionately high for brain disorders due to largely unknown differences in genetic bases between model
species’ and human’s brains, which prevent translational success. A major challenge hindering progress in
neuropsychiatric medicine is our limited understanding of the genetics underlying the complexity of human
brain structure and function. Our first objective in the current study is to uncover genetic variants associated
with brain imaging phenotypes (Aim 1). Our second objective is to test the genetic effects of regulatory and
phylogenically annotated genomic elements on the human brain (Aim 2). Our third objective is to determine the
impact of neuropsychiatric genetic risks and their environmental interactions on the brain (Aim 3). Previously
we produced the first genetic atlas of the human cortex based on magnetic resonance imaging (MRI) data of
twins using fuzzy clustering. This work not only confirmed that human brain phenotypes are heritable traits but
also demonstrated a clear region-specific genetic pattern, which facilitates identification of genetic variants
associated with brain subdivisions. Our recent work demonstrated the value of using this atlas to determine the
segments of the genome that are enriched for genetic effects influencing brain structure. In this proposal, we
will leverage a ten-fold enlarged sample with both MRI and single nucleotide polymorphism (SNP) data, and
advanced genetic and imaging methods to significantly expand the scope of our work. The larger sample
increases power for discovering SNPs associated with individual brain structures and will enable us to examine
genetic heterogeneity by age, sex, and genetic ancestries. Characterizing subgroups is critical for precision
medicine approaches and to increase statistical power using genetically more homogeneous groups (Aim 1).
We will also characterize pleiotropy and regulatory epistasis effects on the brain by multimodal imaging
(structural, diffusion and functional imaging). This will provide insight into shared and distinct genetic influences
among different brain regions. We hypothesize that variations in the highly expanded human cortex are
associated with regulatory genetic effects (Aim 2). Third, building on improved genetic knowledge of the brain,
we will determine its genetic relationship with neuropsychiatric disorders. We will estimate effects of psychiatric
and neurological genetic risks and environmental exposures on deviations of MRI phenotypes from normal
neurodevelopmental and aging trajectories (Aim 3). The current project has strong potential to significantly
increase our understanding of genetic basis of the human brain, and to determine genetic and environmental
factors that drive brain deviations from typical trajectories across lifespan, with a long-term goal to ultimately
improve diagnostics, early intervention and therapeutic development for neuropsychiatric disorders.

Public health relevance
Project Narrative Many devastating human illnesses, such as neuropsychiatric disorders are heritable, but the connection between genes, the brain and brain disorders is not well understood. Through application of genetically-based cortical atlases and state-of-the-art statistical approaches in a large sample with brain imaging and genotyping data, we will increase understanding of the genetic basis of the human brain and neuropsychiatric disorders, which could lead to new insight into disease mechanisms. Understanding genetic and environmental influences on neurodevelopmental and aging trajectories could provide early detection and specify targets for trajectory-altering therapeutics and prevention.